Understanding host-microbiome coevolution and genetic variation in immunity using an insect model system

PROJECT SUMMARY / ABSTRACT
Microbiomes have been described as ‘ecosystems on a leash,’ because immunological control of the
microbiome is critical for host health. Variation in the genes that produce the immune system has been linked
to microbiome dysbiosis and to disease, and studying immune systems in the context of host-microbe
coevolution has generated critical insights. However, we do not understand the evolutionary forces maintaining
host genetic variation related to the microbiome or how immune systems coevolve with beneficial microbes. My
research program takes advantage of several key features of an innovative animal model system: an insect
called the pea aphid. This animal reproduces asexually, and we can precisely manipulate bacterial
microbiomes across asexual lineages by adding or removing specific strains and species of microbes. The
aphid microbiome includes species of Enterobacteriaceae that have clear benefits for their hosts including
protection against pathogens and parasites. These aspects of our model system allow us to untangle the
specific effects of host and bacterial genetic variation on the microbiome, and to study natural and ecologically-
relevant host-microbe pairings. Importantly, my lab has generated key data on the patterns of association
between microbes and host populations, and we have shown that genetic variation in the immune system
governs the association with bacterial symbionts. Over the next five years, we will use techniques adapted
from human innate immunology, functional and forward genetics, and dual-RNAseq of both host and microbes
to understand the roles by which animal immune systems and beneficial microbes evolve in a bi-directional
manner. Our preliminary data suggest that phagocytes control the density of bacterial infections, but that some
strains of microbes have evolved to kill phagocytes to grow to high density. We will test a mechanistic model
for the interaction between phagocytes and beneficial bacterial in the context of host and bacterial genetic
variation. Simultaneously, we will use an F2 cross to determine what kinds of genes underlie host genetic
variation in the microbiome, the patterns of molecular evolution at these loci, and importantly, whether these
genes also govern resistance against often closely-related pathogens. Together, this work will address
fundamental questions relevant to human health, including whether adaptation to beneficial microbes trades off
with the ability to combat pathogens, and how control of the microbiome shapes microbial virulence. This work
will establish a foundation for my lab’s future efforts to develop a comprehensive picture of how natural
selection shapes host traits related to the microbiome in a controlled and tractable model system.

Public health relevance
PROJECT NARRATIVE Animals host complex communities of microbes that are part of the proper functioning of our bodies, and control of the microbiome by the immune system is critical for host health. This project will study how beneficial microbes and animal immune systems coevolve. By seeking this basic understanding of the evolutionary dynamics governing the microbiome, this research is relevant to the NIH’s mission to develop fundamental knowledge of living systems.